RECOMBINANT HIV 1 ENVELOPE ANTIGEN IN CHILDREN BORN TO HIV INFECTED MOTHERS

This project tests the hypothesis that one or more of the recombinant HIV antigens under study will be safe and immunogenic in infants born to HIV-infected mothers.